Dissecting single cell dynamics that coordinate neural crest migration and diversification

RESEARCH SUMMARY
Embryonic development involves the formation of functional organs comprised of many
different cell types, which often originate from different locations. Thus cell migration and
differentiation must be tightly coordinated, but are typically studied as independent
processes. Here we use a combination of gene expression profiling in single cells,
zebrafish genetics and computational models to test the hypothesis that migration and
differentiation are coordinated. This coordination requires specific regulators of cell
adhesion dynamics and cell-cell signaling. We focus on neural crest cells, a transient
embryonic population that migrates throughout the body to give rise to a huge range of
different fates. One barrier to studying this problem has been the limited number of tools
available to detect transitional states in individual cells as they differentiate and tie this to
their migratory behaviors in a precise and quantitative manner. Here we develop new
approaches for profiling gene expression in single cells from known locations and
tracking their movements in vivo. We will analyze how genes required for cell adhesion
and cell-cell signaling influence these processes, and use computational models to
predict key features of neural crest cell responses. We expect that such a
multidisciplinary approach will reveal insights into the mechanisms that integrate cell
migration and fate.

Public health relevance
PROJECT NARRATIVE A major challenge in treating birth defects and developing regenerative medicine is to better understand complex systems of cell fate specification in stochastic and dynamic environments. This application will exploit novel experimental tools and new computational methods to uncover new mechanisms that control fate specification in neural crest cells that form diverse tissues including body pigmentation, the peripheral nervous system and the skull. The expected new results are directly relevant to treating birth defects, regenerative therapy, and therapeutic strategies for the many diseases associated with these derivatives of the neural crest.